Fibroblast lineage tracing in metastatic and pre-metastatic microenvironments

Abstract
Breast cancer is one of the leading causes of cancer-related mortality among women worldwide, and the
overwhelming majority of breast cancer patient deaths are caused by metastatic disease rather than primary
tumor growth. However, the complex process of tumor cell dissemination and colonization of distant tissues is
incompletely understood and is largely incurable using existing therapies. Metastatic disease is particularly
intractable because metastasis is not solely driven by tumor cell-intrinsic properties but is instead a
consequence of dynamic, heterotypic interactions between cancer cells and other cell types in the tumor
microenvironment (TME) including cancer-associated fibroblasts (CAFs). CAFs are a prominent component of
the breast tumor microenvironment and are important during multiple stages of tumor development, including
metastasis. However, CAFs have been shown to display paradoxical functions across different cancer types,
suggesting that heterogeneous CAF subpopulations may play diverse or opposing roles in the tumor
microenvironment. It was recently shown that periostin, a TGFβ-induced matricellular protein that serves as a
protein scaffold to promote collagen cross-linking and extracellular matrix stiffening, can distinguish CAF
subtypes in breast cancer. This specific CAF subpopulation is not well characterized, and its source, functional
properties, and contribution to disease progression have not been studied in vivo. Thus, I propose to use in
vivo genetic labelling/targeting of periostin+ subpopulations and their progeny to better delineate their
expansion and function during breast tumor growth and metastasis. My preliminary data indicates that
ZSGreen-labelled periostin-expressing CAFs are more abundant in the primary tumors and metastases of
high-metastatic breast tumor cells compared to their low-metastatic counterparts. I also observed that the
collagen organization of high-metastatic tumors containing abundant periostin-expressing CAFs is altered, with
high-metastatic tumors displaying long, aligned collagen fibers and low-metastatic tumors displaying
disorganized collagen. Accordingly, I found that knocking down periostin in primary human CAFs inhibits tumor
cell invasion through collagen in a CAF/tumor cell co-culture spheroid assay, indicating that periostin-
expressing CAFs may remodel the extracellular matrix via collagen cross-linking, making it more conducive to
cell migration and invasion. In addition, I observed that ZSGreen+ cells in highly metastatic tumors are larger
and more spindle-shaped, and that periostin knockdown in primary CAFs reduces their cellular area and ability
to migrate, suggesting that periostin is associated with biomechanical properties of CAFs that function in cell
spreading and motility. I propose that high-metastatic cancer cells have an enhanced ability to activate
periostin-expressing CAFs, driving their proliferation and expansion in the TME and subsequently promoting
collagen remodeling and collective cell migration of CAFs and cancer cells, resulting in metastasis.

Public health relevance
Project narrative Breast cancer is the leading cause of cancer-related mortality in women worldwide, and metastatic disease is the primary cause of death in the majority of breast cancer patients who succumb to the disease. Cancer- associated fibroblasts (CAFs) are a prominent component of the breast tumor microenvironment and are associated with multiple stages of tumor development, including metastasis, though their specific contributions to disease progression remains controversial. The experiments in this proposal will explore the differences in the distribution, function, and molecular characteristics of CAFs in low- versus high-metastatic breast tumor models in order to improve our understanding of the dynamic tumor microenvironment and to ultimately leverage this knowledge to improve the outcome of patients with metastatic disease.